A web-based program to improve chronic illness self-management by engaging patients and informal caregivers

Background: For the 80% of older Americans who have at least one chronic condition, sharing self-
management responsibilities with caregivers (relatives or friends) predicts longevity, better health, better
quality of life, and fewer hospitalizations. Caregivers often support patients in their self-management efforts.
This can bring patients and caregivers closer but can also generate stress for both that can interfere with self-
management. Yet, self-management programs rarely support the coping needs of patient-caregiver dyads.
Significance: There are more than 5 million caregivers of Veterans; 75% of older Veterans receive some
caregiver support. Caregivers incur individual financial and emotional costs even as they provide unpaid care.
Having an effective self-management strategy that addresses the needs of both can improve outcomes and
quality of life for millions of Veterans who suffer from chronic illnesses and their caregivers. This project
addresses the priorities “Long-term care and Caregiving,” “Virtual Care/Telehealth,” and “Access to Care” and
is consistent with the legislative goals of the MISSION Act.
Innovation and Impact: This highly innovative proposal uses the novel concept that strengthening the
interpersonal relationships between Veterans and caregivers can improve the self-management of chronic
conditions. It challenges current clinical paradigms by addressing the collective stress coping needs of dyads.
It is methodologically innovative because unlike many behavioral intervention trials, it assesses barriers and
facilitators to plan for future implementation. Our focus on technology-enabled tools is timely given how
COVID19 has transformed care delivery. This project takes advantage of the unique capabilities of the VA
health system to explore questions including robust caregiver support and virtual care programs.
Specific Aims: With investments from VA HSR&D, we have developed and successfully pilot tested a new
theoretically-derived technology called Web-based Self-care Using Collaborative Coping EnhancEment in
Diseases (web-SUCCEED). We propose to conduct a randomized clinical trial comparing web-SUCCEED to
an enhanced usual care (EUC) control. We will conduct a formative evaluation guided by the Consolidated
Framework of Implementation Research (CFIR) to accelerate future implementation.
1. Assess whether web-SUCCEED improves Veteran outcomes of self-management compared to EUC, 4
weeks and 6 months following randomization.
2a. Assess whether web-SUCCEED improves patient stress and quality of life.
2b. Assess whether web-SUCCEED improves caregiver stress, quality of life and caregiver burden.
2c. Examine communication, dyadic coping, mutuality, and relationship quality as mediators of primary and
secondary outcomes (Aims 1, 2a, 2b).
3. Guided by CFIR, conduct a formative evaluation involving key stakeholder interviews to understand barriers
and facilitators of future implementation.
Methodology: We will recruit 280 cognitively intact Veterans from VA Palo Alto Health Care System who are
managing at least one common chronic condition, and their caregivers. Veteran-caregiver dyads will be
randomized 1:1 to web-SUCCEED or EUC. Veteran and caregiver assessments will take place at baseline,
then again at 4 weeks and 6 months. The formative evaluation will be guided by CFIR and involve semi-
structured interviews with clinical staff, providers, and facility leaders in Year 4.
Next Steps: Our formative evaluation will set us up for implementation studies to evaluate web-SUCCEED in a
wider array of clinical settings and facilities. Existing operational partnerships will facilitate wider clinical
implementation and moving research into practice. Our innovative project, strong investigative team and
operational partnerships will ensure a successful study that has the potential to shift clinical paradigms.

Public health relevance
The majority of Veterans will suffer from at least one chronic illness, often at great emotional and personal cost. Self-management is critical to improving physical and emotional outcomes, and many chronically ill Veterans receive self-management assistance from an informal caregiver. Yet, current clinical practices are not designed to effectively support the needs of both Veterans and their caregiver. Furthermore, self-management practices are often taught in person to the detriment of Veterans who face barriers to attending such as Veterans who live in rural areas, experience functional limitations, or experience financial challenges. This project tests a web-based self-paced behavioral intervention that targets the individual and interpersonal stress coping needs of Veterans with chronic illness and their caregivers. Results could provide an important solution to the problem of poor self-management which complicates the lives and prognosis of many Veterans.